LONG-TERM TREATMENT AFFECT ON HYPOTHALAMIC-PITUITARY REGULATION OF PROLACTIN

To examine the effects of bromocriptine used on long term treatment of prolac tinomas. Comparison of prolactin responses to provocative stimuli before and after treatment. To determine pre-treatment response patterns to stimuli that predict which patients remain in remission after treatment. To compare bioactivity of circulating prolactin before, during and after treatment.